Lipid Flippases in the Function and Degeneration of Sensory Hair Cells

Project Abstract
The cochlea of the inner ear houses sensory hair cells responsible for detecting auditory signals. Since hair
cells do not regenerate, their loss leads to permanent hearing impairment, making it essential to understand
the molecular mechanisms underlying their degeneration to develop effective therapies. At the apex of each
hair cell is the hair bundle, a specialized structure that detects sound-induced mechanical vibrations. These
vibrations open mechanosensitive ion channels, leading to hair cell depolarization. While the roles of proteins
within the hair bundle are well-studied, the importance of the plasma membrane's lipid composition in hair
bundle function and maintenance remains poorly understood. Of particular interest is the asymmetric
distribution of phosphatidylserine (PS), which is typically confined to the inner leaflet of the membrane.
Ototoxic insults, such as loud noise and aminoglycosides, disrupt lipid homeostasis in the hair bundle, though
the exact mechanisms and their effects on hair cell function are unclear.
This proposal investigates how phospholipid homeostasis regulates hair cell function and health using mice
deficient in the phospholipid flippase ATP8B1 or its cofactor TMEM30B, which experience rapid hearing loss.
These models provide a framework to explore the link between lipid dynamics and auditory function. Previous
research suggests that ATP8B1 deficiency leads to hair cell degeneration and deafness, though the underlying
mechanisms remain unknown (Stapelbroek et al., 2009). We hypothesize that ATP8B1 is essential for
maintaining the lipid environment required for proper mechanotransduction. To address this hypothesis, we will
first define the developmental timeline of ATP8B1 and TMEM30B expression and investigate whether their
localization to the stereocilia depends on mechanotransduction (MET) or TMC1 activity. We will also determine
how ATP8B1 loss impacts hair cell function, plasma membrane asymmetry, MET currents, and cell survival,
aiming to uncover ATP8B1’s role in stereocilia and its contribution to the proper lipid environment for hair cell
MET. Lastly, we will assess whether TMEM30B alone qualifies as a deafness gene by conducting auditory
brainstem response and distortion product otoacoustic emission testing, alongside evaluations of hair bundle
morphology and plasma membrane asymmetry. This research will illuminate the critical role of the lipid
membrane environment in hair cell function and longevity. Insights gained could advance our understanding of
how disruptions in lipid homeostasis contribute to hearing loss, paving the way for innovative therapeutic
strategies.

Public health relevance
PROJECT NARRATIVE This proposal will describe a previously unknown mechanism of a genetic form of hearing loss in the mammalian cochlea. Data generated from these experiments will build upon our knowledge of the function of both membrane asymmetry and the role of proteins in maintaining cochlear function. Understanding this process could provide insight into the prevention of hearing loss, which affects approximately nearly 73 million Americans (Johns Hopkins Cochlear Center for Hearing and Public Health.).